CAROLINA CANCER NANOTECHNOLOGY TRAINING PROGRAM (C-CNTP)

This proposal seeks competing continuation of the NIH T32 Carolina Cancer Nanotechnology Training Program
(C-CNTP). The program started in 2015 with the support of the NIH Ruth L. Kirschstein National Research
Service Award. The goal of the program is to make a major contribution to the growth of the cancer
nanotechnology workforce by providing training and research experience to a highly select cohort of postdoctoral
fellows. During four years since its initiation the program has recruited 15 excellent fellows of whom 5 have
completed training and moved into tenure track assistant professors, industry and FDA positions, 8 continue
training with the NIH T32 support and 2 are in the final stages of training with other support sources in the labs
of their mentors. We have assembled a team of 20 outstanding Program faculty from 11 departments and 3
schools at the University of North Carolina Chapel Hill with specific expertise in physical and material sciences,
chemistry, pharmacoengineering, drug delivery, computational modeling as well as basic biomedical research
and clinical science, all of whom have demonstrated strong interests, capabilities and collaborations at the
interface between nanoscience and cancer. The objectives of the C-CNTP are to: 1) recruit an elite group of
talented postdoctoral fellows from diverse backgrounds with PhD, MD or PharmD and provide them with
outstanding postdoctoral experience including focused didactic training and co-mentored research experience
with faculty mentors from complementary fields; 2) provide each trainee with intensive introductory training with
online video library of recorded lectures followed by workshops and didactic courses to remediate differences in
their backgrounds and to deepen the knowledge and understanding in the key areas of cancer nanotechnology;
and 3) facilitate transition of trainees to independence by providing them with opportunities to a) conduct original
cancer nanotechnology research projects; b) apply for the individual cancer nanotechnology Pilot Grants within
C-CNTP, and c) acquire written and oral communications skills needed to publish manuscripts, report results,
and write successful individual extramural support applications focused on problems of cancer nanotechnology.
We are committed to developing a world-class postdoctoral training program that capitalizes on the existing
strengths in cancer nanotechnology research, consolidates diverse research and education resources across
several academic units, and becomes a significant contributor to addressing the Nation's research needs in
cancer nanotechnology.

Public health relevance
This multidisciplinary five-year program is designed to train postdoctoral research fellows working at the intersection of nanoscience and cancer research. The goal is to prepare scientists who will successfully pursue careers in academia, industry, and government agencies, and will become significant contributors to addressing emerging challenges in public health and medical research using nanotechnology to diagnose and treat cancer.